Family resources, food security, and child health during periods of temperature change and adverse climate conditions

SUMMARY
This project will use data from randomized controlled trials of cash transfers to poor households in Zambia and
Kenya to test whether these programs can protect food security, child health and youth lifecourse transitions
during periods of adverse climate conditions. Specifically, we will link longitudinal household data from these
two geographically dispersed trials to daily, high-resolution data on temperature and precipitation exposures.
We will then take advantage of the randomization of transfers and the effective randomization of climate
anomalies at the community level to test whether transfers modify the effects of climate shocks on a rich set of
household, child and youth outcomes. This will represent the one of the first studies to test whether transfers
can protect children and youth against temperature exposures, and will directly feed into the ongoing global
conversation about how best to protect vulnerable populations against climate change.

Public health relevance
NARRATIVE Climate change is expected to have important negative consequences for the health and living standards of vulnerable populations in low and middle-income countries, but to date there are few population-based strategies that have been documented to help protect against these exposures. We will use data from randomized controlled trials of cash transfers to poor households in Zambia and Kenya to test whether these additional resources can protect food security, child health and youth lifecourse transitions during periods of adverse climate conditions.